Invasion and intracellular replication of Salmonella Typhimurium in epithelial cells

Salmonella enterica serovar Typhimurium (S. Typhimurium) is a common cause of enterocolitis in humans and cattle but causes a systemic, typhoid-like, disease in susceptible mice. This facultative intracellular pathogen invades non-phagocytic cells, such as those found in the intestinal epithelium, and survives within a modified phagosome known as the Salmonella-containing vacuoles (SCV). Two type III secretion systems (T3SS), which translocate distinct cohorts of bacterial effector proteins into the host cell, are required for establishment of the intracellular replicative environment. Invasion is dependent on T3SS1 whereas T3SS2 is induced intracellularly and is associated with intracellular survival/replication and biogenesis of the SCV. A very important aspect of the host-pathogen interaction is the biogenesis of the SCV, from initial formation through to the ultimate release of bacteria. We have previously shown that SCV biogenesis involves sustained dynamic interactions with the endocytic pathway including late endosomes and lysosome. More recently we have shown that, in epithelial cells, a significant percentage of intracellular Salmonella escape from the SCV and replicate within the cytosol. One of our main interests now is to determine the relative importance of vacuolar versus cytosolic replication in epithelial cells.